Afferent Mechanisms of Vagal Neuromodulation Therapy

1 Project Summary
2
3 Vagal nerve stimulation (VNS) therapy is approved for three central nervous system disorders. Despite promising
4 preclinical evidence of success amelioration of heart failure, several large patient trials have failed to meet
5 designated endpoints. Remarkably many recommended clinical protocols for VNS therapy appear to violate
6 strong preclinical evidence as well as approved therapies that rely on vagal afferent activation of central nervous
7 mechanisms. Low intensities of clinically tolerated VNS activate myelinated vagal afferents and these activate
8 neurons within the nucleus of the solitary tract (NTS). Preclinical data on vagal NTS neurons outline multiple
9 mechanisms controlling successful vagal transmission but indicate that current clinical VNS protocols likely
10 engage substantial frequency dependent transmission depression within NTS. Our global hypothesis is that VNS
11 drives central nervous system (CNS) pathways that contribute to beneficial therapeutic outcomes. Our goals are
12 to identify the mechanistic basis for processes contributing to optimal VNS therapy. Activation of the CNS by
13 VNS requires successful activation of action potentials in NTS neurons. We found that midcollicular knife cuts
14 eliminate pathways above the medulla and profoundly reduced VNS activation of NTS neurons. Our work will
15 examine the contribution of the paraventricular nucleus of the hypothalamus (PVN). Our experimental design
16 assays cellular mechanisms of NTS activation in brain slices as well as single NTS neurons in intact animals.
17 Hypotheses related to PVN will center on potential mechanisms of NTS modulation including roles for the
18 neuropeptides, vasopressin and oxytocin. New optogenetic experiments will incorporate transfections of PVN
19 neurons that are activated by VNS to expression ChR2 or halorhodopsin to control these neurons via light. Our
20 Aims focus on weak-intensity, vagal afferent activation of the CNS. Our approach relies on our direct assays of
21 NTS neuron activation – both in the intact brain as well as brain slice, intracellular recordings of NTS in vitro. We
22 propose Specific Aims supported by Preliminary Results that will identify the mechanisms for amplification and
23 spread of VNS excitation. Aim 1 focuses on potential mechanisms within NTS with emphasis on vagal timing
24 and synaptic depression while Aim 2 assesses mechanisms related to PVN modulation of NTS neurons with a
25 particular focus on oxytocin and vasopressin. Aim 3 assesses vagal afferent transmission in heart failure animals.
26 Aim 4 evaluates the therapeutic efficacy of VNS to relieve heart failure in a rat model. This proposal embraces
27 an assessment of whether optimizing activation of NTS neurons will enhance VNS efficacy in a heart failure
28 model. This work addresses a fundamental knowledge gap of neuromodulation therapy. Greater knowledge of
29 visceral afferent processing should drive new stimulation approaches in all clinical applications. We aim to
30 provide a knowledge foundation necessary for deliberate, evidence-based criteria for VNS therapy to improve
31 clinical outcomes.

Public health relevance
Vagal nerve stimulation therapy has been approved for three central nervous system disorders but large patient trials for heart failure have failed despite promising preclinical evidence of success. We propose that appropriate consideration of vagal afferent central transmission is key to designing optimally effective therapeutic protocols for vagal nerve stimulation. Our preliminary evidence suggests that signals from the paraventricular nucleus of the hypothalamus contribute to therapeutic efficacy in heart failure.